The Stanford-SLAC CryoEM Center (S2C2)

Project Summary This is a supplement request for providing a cryo-specimen screening service to the community. We will use our existing equipment in the Center to provide this activity. We anticipate that the Talos Arctica (200 kV) and the Tundra (100 kV) electron microscopes will be used for the proposed activity. We will recruit a full-time staff member for this activity and will advertise our service through 3DEM and our user email lists. We anticipate that this service will expand the dissemination of cryoEM technology to investigators who do not have expertise or facilities in their institutions. All the users need to apply this service via our existing project application process and evaluated by our user project evaluation committee prior to allocating staff and instrument time for the approved projects.

Public health relevance
Project Narrative The Stanford-SLAC Cryo-EM Center has the dual mission of providing the community with cryo- electron microscopes for data collection and cross-training personnel from any research institutions to become independent cryo-EM investigators. In this supplement proposal, we would like to request funding to provide specimen screening service to the community using the existing infrastructure of our Center.